Data Science Resource

DATA SCIENCE RESOURCE SUMMARY
The HHEAR Data Science Resource (DSR) will accelerate research in environmental health sciences by
creating a community-vetted HHEAR ontology that is used to power the HHEAR data portal, and more broadly
to facilitate connections between a wide range of environmental health data. The DSR provides ontology
expertise, ontology identification and mapping criteria, community outreach and engagement, and overall
semantic guidance to support the HHEAR Data Center's data portal that provides findable, accessible,
interoperable, and reusable exposure and health data. The DSR focuses on interoperable terminology
connecting to and leveraging best-in-class vocabularies, including the evolution of our current CHEAR ontology
into an HHEAR ontology as needed for the broader scope and new study support. Indeed, our experiences in
building the CHEAR ontology inform and guide our plans for HHEAR. We also aim to actively lead and
continue to build an exposome and health community striving toward best practice data and metadata
vocabularies and standards, with reuse and link as appropriate. The resource contributes semantic leadership,
processes, tools, and semantic design and infrastructure evolution consulting to support finding, prioritizing,
analysis for gaps/coverage, and effectively using appropriate vocabulary and use cases. Guided by experts in
data science, bioinformatics, and domains, we will actively co-lead and participate in community working
group(s) with the aim of creating open-source, community-driven annotated collections of data and metadata
standards. Ultimately, these goals have the potential to provide a community-driven and community-accepted
language for exposure science. Further, the methodologies are being designed with a goal of living beyond this
program, providing guidance for future participants and communities. The ontology and the process facilitates
the goals of the HHEAR Program in expediting progress in exposome-related research, analyses, and
collaborations, most notably by having unambiguous use of terminology and processes for updates.
The DSR's specific aims are to provide the program-wide HHEAR ontology along with criteria for evaluating
and cataloging relevant standards. We will co-lead community engagement and outreach, and support the
DRMC in ontology usage of the Data Center's robust data harmonization and access portal. Leveraging our
existing infrastructure and expertise will overcome the need for a long implementation process fraught with
challenges—we have already encountered and overcome many such challenges in implementing the CHEAR
DC, and will be able to flexibly respond to the needs of the HHEAR Network.